Genetic and environmental contributions to obesity pathogenesis

PROJECT SUMMARY ABSTRACT
The genetic basis of obesity is well documented through classical twin studies and modern sequencing
methods that generate genome-wide polygenic risk scores. The strong influences of socioeconomic,
environmental, and health-behavior risk factors for obesity have also been identified. However, neither genetic
nor environmental factors alone can explain the rapid rise in obesity prevalence over the past forty years. It is
likely that the underlying biological drivers of the obesity epidemic lie at the intersection of genetics and the
modern environment. The overall goals of the proposed research are to fill gaps in our understanding of the
neurobiological underpinnings of genetic risk factors for common obesity, and to probe mechanisms whereby
genetic factors may magnify the risk of environmental exposures through effects on the brain. Specifically, rodent
models indicate that dietary exposures cause cellular inflammation – known as gliosis – in the mediobasal
hypothalamus, which contains the arcuate nucleus, leading to dysfunction of local neurons that regulate body
weight, increases in adiposity, and obesity. The cumulative literature from translational studies supports a role
for hypothalamic inflammation and gliosis in the pathogenesis of obesity in humans. However, genetic
susceptibilities that modify the extent to which obesogenic diets stimulate hypothalamic inflammation and gliosis
remain largely uninvestigated. It is also possible that potent environmental stimuli promote hypothalamic gliosis
regardless of genetic makeup which could have broad implications for population health. The proposed research
therefore uses epidemiologic and twin study approaches to 1) test genetic risk factors for hypothalamic gliosis
and 2) test environmental risk factors for obesity and hypothalamic gliosis and determine, through twin study
methods, if environmental factors act independently of genetic background to promote obesity and/or
hypothalamic gliosis. The proposed studies will utilize genetically informative samples from the Framingham
Heart Study, the Adolescent Brain Cognitive Development Study, a brain tissue repository, and the Washington
State Twin Registry. Hypothalamic gliosis will be measured both in vivo using magnetic resonance imaging and
post-mortem using histopathology performed on hypothalamic tissue. Genotype-phenotype association study
designs include both candidate gene and genome-wide approaches. Twin studies are used to disambiguate
inherited, environmental, and health behavior risk factors for obesity and hypothalamic gliosis. In sum, the
proposed research could significantly impact the field by uncovering molecular and neurobiological pathways
involved in obesity pathogenesis, advancing our understanding of the influence of genetic factors on
hypothalamic inflammation and gliosis, and opening avenues for novel mechanistic studies or precision health
interventions.

Public health relevance
PROJECT NARRATIVE Obesity remains a pressing public health concern, with significant consequences for individuals and society. Improving health outcomes for people with obesity requires increasing knowledge about what factors might predispose—or protect—individuals from weight gain over time. The proposed research investigates both genetic and environmental factors that, through their effects on body-weight regulating areas of the brain, might promote obesity in susceptible individuals.